Research Education Program for Minority Medical Students

PROJECT SUMMARY / ABSTRACT ! The primary objective of the proposed research education program is to provide annual short-term (10 week) research education experiences for 10 highly motivated minority students in order to expose them to biomedical research in the area of cardiovascular function and disease. The long-range goal is to increase the number of minority health professionals in this area through interest generated by exposure to a broad spectrum of research and educational activities. The program builds upon MUSC's established strength in cardiovascular research, its strong commitment to providing meaningful research training experiences for students at all levels, and its track record of introducing students from underrepresented groups to biomedical research. The Program Faculty is a group of 31 productive, collaborative, independently funded scientists with strong training records whose expertise and interests are highly relevant to the cardiovascular sciences including multiple aspects of cell communication and molecular structure and their dysfunction in cardiac morphogenesis, hypertension, vascular disease and cardiac hypertrophy and failure. They also include faculty with interest in diseases and disorders that exhibit significantly higher rates of incidence, morbidity, and mortality among African American residents of South Carolina than among other population groups, or even African Americans in other parts of the country. In addition to the mentored research project and instruction in the ethical conduct of research, students will participate in a Cardiovascular Seminar Series and a course in Introduction to Critical Review. Senior research electives allow students to gain additional research experience and exposure to patient-oriented research during their advanced years in medical school. The program benefits from a stable administrative structure and exceptionally strong leadership committed to diversity. A comprehensive evaluation plan that measures the degree to which the program is achieving its objectives is also in place. !

Public health relevance
PROJECT NARRATIVE The goal of this program is to give talented first year medical students from underserved groups short-term (10-week) biomedical research experience in the area of cardiovascular function and disease. Our long-range goal is to increase the number of minority health professionals in this area through interest generated by exposure to a broad spectrum of research and educational activities. !